F32 - Bitter chemosensation from gut to brain

PROJECT SUMMARY/ABSTRACT
A substantial part of our diet and health regime involves bitter food and medicine. Bitter molecules bind bitter
taste receptors (Tas2rs) and activate a sensory pathway that elicits an aversive taste sensation in the oral
cavity, mainly to avoid ingestion of toxins. Tas2rs are also found throughout the digestive tract, and bitter
stimuli in the gut aﬀect feeding behavior through gut peptide secretion and stimulation of sensory regions in
the brain through the vagus nerve. Yet, it remains to be determined how sensory signaling from ingested
bitter molecules are transduced from gut to brain. Our lab discovered a population of specialized gut
enteroendocrine cells, called neuropod cells, that detect luminal nutrients in through apical sensors and
transduce sensory signals to the brain in milliseconds, via the vagus nerve. This gut sensory pathway
regulates feeding behavior in real-time. The hypothesis of this application is that neuropod cells detect bitter
signals through Tas2rs and transduce them onto vagal neurons. Preliminary ﬁndings show that isolated small
intestinal neuropod cells are enriched for a subset of murine Tas2rs, compared to all other intestinal epithelial
cells. Expression of these Tas2rs is dynamic, as it decreases in response to bacterial endotoxins. Therefore,
neuropod cells may act as gut sensors for bitter compounds to communicate the valence of bitter molecules,
which range from toxic to medicinal. Speciﬁc aim 1 will determine whether neuropod cells are activated by
bitter stimuli through Tas2r signaling. Expression of Tas2rs and their signaling molecules will be characterized
throughout the gut and activation of neuropod cells in response to bitter molecules will be determined by
calcium imaging. The requirement of Tas2rs for bitter signaling in neuropod cells will be determined through
targeted knockouts of Tas2rs. Speciﬁc aim 2 will determine whether neuropod cells signal luminal bitter
stimuli onto vagal neurons. The signaling molecule will be identiﬁed by release assays in intestinal organoids
and single neuropod cells in response to bitter molecules, and the sensory pathway will be determined by
measuring vagal activation by electrophysiology, in response to gut infusions of bitter molecules. Finally,
pharmacological and optogenetic inhibition approaches will determine the requirement of neuropod cell
signaling for this sensory pathway. This work will uncover how bitter stimuli in the gut are conveyed to the
brain, bringing forth a new aspect of chemosensation and gut-brain communication for a variety of foods and
medicine that are essential for our health.

Public health relevance
PROJECT NARRATIVE Bitter taste in the oral cavity serves as an aversive warning signal, yet we regularly consume bitter food and medicine. In the gut, bitter molecules control digestive function and appetite, but the gut sensory pathway for bitter signals has not yet been determined. This proposal will deﬁne how chemosensory signals from bitter molecules are detected in the gut and transmitted to the brain.